Mechanisms of Odor Detection and Discrimination

Project Summary
A fundamental goal of sensory neuroscience is to understand how external signals from the
environment are detected and translated into neural signals that underlie perception and enable
discrimination of different stimuli. In the mammalian olfactory system, odorant detection and
discrimination are mediated by hundreds of distinct odorant receptors (ORs) tuned to detect
small, volatile molecules with diverse physicochemical properties. To understand the neural
basis of olfactory sensation it is necessary to determine the nature of OR sensitivity and
selectivity across olfactory chemical space, as well as how OR – odorant interactions drive
neural activity. The proposed project addresses these goals by investigating OR selectivity and
function at multiple levels for three ORs in the mouse olfactory system. The project builds on a
well-established collaborative pipeline between the two co-Investigators that allows for
predictions arising from structure-function studies and in vitro assays to be tested in vivo for the
same ORs. The project is organized around two major Aims. Aim 1 will investigate the structural
determinants of OR activation and corresponding neural signaling in awake, freely breathing
mice. We will focus on three ORs – one Class I and two Class II ORs – where high-potency in
vivo ligands and glomerular projection targets have already been identified and use OR-IRES-
mKate2 gene knock-in mouse lines (already generated) crossed with lines expressing the latest-
generation optical reporters (GCaMP8m) expressed in either olfactory sensory neurons or
mitral/tufted cells. We will compare in vitro activation profiles and in vivo response features for
each OR and test hypotheses for how OR activation translates to in vivo neural activity patterns
at each level. Aim 2 will investigate the structural basis and in vivo efficacy of OR antagonism,
which is hypothesized to shape the encoding and perception of odorant mixtures but is poorly
understood. We will test a novel model of the structural basis for antagonism of an identified
Class I OR using in vitro functional assays, then define the efficacy and specificity of OR
antagonism in shaping odorant-evoked neural activity in the awake mouse. Completion of these
Aims will provide new foundations for linking the understanding of olfactory sensing
mechanisms from the level of ORs to the brain, pave the way for rational design of OR
antagonists, and ultimately achieve a generalizable understanding of the relationship between
OR structure, ligand selectivity, and OR-driven neural activity in vivo.

Public health relevance
This project aims to understand how odorant receptors detect and translate environmental signals into neural activity, focusing on their sensitivity, selectivity, and the resulting neural patterns. It involves investigating the structural basis and in vivo efficacy of receptor activation and antagonism using advanced in vitro and in vivo methods. The goal is to provide new resources and methodologies to accelerate the field of olfactory research and design predictive models for olfactory perception.